A translational bioinformatics approach to elucidate and mitigate polypharmacy induced adverse drug reactions

PROJECT SUMMARY
This proposal for a mentored career development award consists of a training and research plan to facilitate Dr.
Zackary Falls' transition to an independent investigator focusing on translational bioinformatics for patient tailored
predictive analytics related to opioid addiction severity. The opioid epidemic is a major concern in the United
States that is exacerbated due to the high prevalence of prescribing two or more drugs to patients living with
opioid use disorder, which increases the likelihood of adverse drug reactions (ADRs) occurring in these patients.
Knowing and predicting drug–drug interactions (DDIs) and resulting ADRs is critical for the safety of patients, but
ADR prediction software tools used in clinical practice have many limitations. Firstly, most DDI databases used
in these software tools are incomplete because they incorporate only pair–wise DDIs. Additionally, most software
tools do not incorporate biological mechanism of action information for the drugs and omit relevant patient–
speciﬁc clinical data such as diagnoses, tobacco use, etc. Dr. Falls aims to exceed the efﬁcacy of these software
with the creation of embedded representations for each patient's prescription proﬁle, leveraging both drug–protein
interaction knowledge about the prescription drugs and patient level clinical data pertaining to polypharmacy and
ADRs. The speciﬁc aims of this research are to predict and validate novel off–target proteins for opioids and
other commonly co–prescribed medications (Aim 1), extract polypharmacy interactions and ADR relationships
from electronic health records of opioid prescription patients (Aim 2), and design a patient personalized software
that uses deep–learning architecture to predict severe ADRs caused by opioid related polypharmacy interactions
(Aim 3) to be integrated with clinical decision support systems for the beneﬁt of patients and clinicians. The ap-
plicant has detailed a rigorous plan containing three career development goals for gaining the skills and expertise
to accomplish his research aims. These goals include: Goal 1. Gain knowledge in addiction research and phar-
macology as it relates to opioid use, Goal 2. Acquire advanced statistical analysis skills for clinical datasets, and
Goal 3. Increase understanding of graph theory and knowledge graph implementation. The team of mentors and
collaborators that has been assembled by Dr. Falls, including Prof. Ram Samudrala as primary mentor, perfectly
accounts for expertise in research areas that the applicant will be investigating and have knowledge in domains
that complement his own understandings to aid in the career development aspect of this proposal. Dr. Falls has
the aptitude, creativity, and perseverance to become an excellent researcher. The support of this K01, guidance
from his terriﬁc team of mentors and collaborators, and the inﬂuence of a rich research environment will enable
him to further develop his skills and knowledge. He will surely accomplish all of his career development goals
and research aims, become a successful independent investigator, and ﬂourish in his career.

Public health relevance
PROJECT NARRATIVE The increasing incidence of patients on two or more prescription drugs creates increasing chances of nega- tive drug interactions, so improved methods for identifying and predicting deleterious, and possibly lethal drug combinations, particularly for interactions with opioids, are desperately needed. I will use a unique translational bioinformatics approach to predict adverse drug reactions for patients by leveraging: the proteins with which each drug interacts, each patient's prescription drug regimen, and patient speciﬁc demographic information. The out- come will be an effective software to predict adverse drug reactions caused by opioid related polypharmacy that will aid clinicians by optimizing prescribing practices for patient safety.